Development of an Organoid-Derived Exosome Product for the Treatment of Osteoarthritis

Summary/Abstract
Osteoarthritis (OA) is a chronic debilitating joint disease, affecting over 32 million people in the USA with an
economic impact of $550 billion/year. OA is characterized by degeneration of articular cartilage, typically
affecting the back, hands, knees, and hips. A significant correlation between inflammation and disease severity
has been observed in human and animal models of OA. Increased inflammation in the synovial fluid has also
been shown to inhibit chondrocyte proliferation limiting cartilage repair and promoting OA disease progression.
No therapy is available to slow the progression of OA and current treatments only attempt to relieve the
symptoms. New therapeutics that promote regulation of inflammation have the potential to alleviate the OA
pathology and arrest the disease progression. The impact of fetal development on the immune system varies
depending on the stage of embryo development with a delicate balance between immune tolerance and protective
immunity. Several extrinsic and intrinsic factors through epigenetic and transcriptional programs skew the adaptive
immune response towards increased expression of immunosuppressive signaling intermediates including Helios that
favors the expansion of Tregs. Exosomes play a critical role in cross talk between different biological systems. In this
study we will leverage the immunoregulatory mechanisms in play during the fetal development to treat OA by
identifying the stage of muti-tissue organoid (MTO)-development that yields exosomes with anti-inflammatory and
chondrocyte proliferation potential in in vitro studies using human PBMCs to facilitate clinical translation. We will
analyze the epigenetic and transcriptomic reprograming induced by the MTO-derived exosomes that promote
expansion of iTregs that can play a critical role in the regulation of inflammation in OA. We will also test the MTO-
derived exosomes to alleviate OA symptoms in a rat model of OA. The studies will also identify protein and miRNA in
the MTO-derived exosomal cargo that correlates with anti-inflammatory and chondrocyte proliferation potential that
can be developed into potency assays for use in future clinical trials for evaluation of the MTO-derived exosomes.

Public health relevance
Narrative A significant correlation exists between inflammation, defects in chondrocyte proliferation, and cartilage repair in osteoarthritis (OA) patients and animal models. In this study, we will exploit the immunoregulatory mechanisms in play during the embryo development to develop a novel therapeutic to treat OA by utilizing multi-tissue organoid (MTO)-derived exosomes to regulate inflammation and promote chondrocyte proliferation, which will facilitate cartilage repair to alleviate the symptoms and arrest disease progression.